Mucosal B-cell aging in PLWH

PROJECT SUMMARY/ABSTRACT
Overall, the world population is aging and in the era of anti-retroviral therapy (ART) people living with HIV
(PLWH) live longer. ART has converted HIV infection into a survivable chronic infection; however,
comorbidities are a mounting clinical reality, likely related to accelerated immunosenescence. It is well
documented that HIV infection leads to accelerated aging, and HIV-1 chronic infection is considered a good
model for studying immunosenescence. The impact of aging on increased susceptibility to infections and
reduced responsiveness to vaccines is a well-known clinical problem. Antibodies are one of the first and most
important responses against pathogens and the reason for this dampened immune response with aging may
be due to age-related reduced humoral immunity (B cell immunosenescence). Humoral immunity has been
understudied in humans, particularly in lymphoid tissue, due to the difficulty of sample availability. It is not clear
how accurately changes observed in blood reflect immunosenescence processes in tissues, especially the
gastrointestinal mucosa which contains most of the body’s lymphocytes (~60%) and it is a region of high
antigen exposure. Therefore, gut-associated lymphoid tissue (GALT) represents a good model to study
lymphoid tissue in humans that is highly exposed to antigen stimulation. A growing body of literature has begun
to reveal the pathophysiological processes driving immune dysfunction of T cells, including work by our team,
which has studied the human mucosal immune compartment. It is not well understood how aging depresses
humoral immunity and there are little or no studies on humoral immunity in the mucosal immune compartment.
Compared to blood, gut mucosa contains fewer naïve cells, more activated memory cell, and more antibody
secreting cells, consistent with the high level of antigen exposure. Therefore, in this study, we propose to
analyze the individual and combined impact of age and HIV-1 on immunosenescence of humoral
immunity, especially in the highly immune active gastrointestinal tract, by quantifying B-cell immune
aging in GALT and peripheral blood in PLWH, as a model of accelerated aging, and in people without
HIV (PWOH). Our hypothesis is that natural aging and HIV-1-induced-accelerated aging diminishes the
capacity of the immune system to produce efficient antibody responses in the periphery and GALT; this will be
a result of inappropriate accumulation of memory-effector T-cells fueled by chronic persistent viral infections,
causing ineffective follicular helper T-cells, inefficient recall of cytotoxic responses, and a generalized,
persistent low-level inflammatory state. The Specific Aims to test this hypothesis are: Aim 1: To determine
age-related B cell lymphocyte senescence in the GALT versus peripheral blood compartments of PWOH and
PLWH ranging in age from 18 to ≥60-65 years. We will also study the functional aspects of B cells in terms of
antibody production and B cell receptor repertoire. Aim 2: To determine if the accelerated B lymphocyte
senescence seen in GALT affects humoral responses, using SARS-CoV-2 as a neoantigen challenge model.

Public health relevance
PROJECT NARRATIVE/ RELEVANCE TO PUBLIC HEALTH Older individuals respond poorly to infectious agents/vaccines due, in part, to aging of the immune system (immunosenescence), a process accelerated in HIV+ individuals that is poorly understood, especially in the gastrointestinal tract, which houses more than 60% of the body’s immune cells. In this study, we aim to understand the effects of aging alone and in combination with chronic HIV infection in mucosal B-cells by studying humoral immunity to SARS-CoV2. This is of great importance as it will aid to identify possible therapies to slow or improve immunosenescence.